HIV IMMUNOGLOBULIN IN PREGNANT WOMEN &NEWBORNS IN PREVENTING TRANSMISSION

A Phase II Study of Hyperimmune AntiHIV Intravenous Immunoglobulin (HIVIg) in Pregnant Women and Their Newborns in Preventing Maternal/Fetal Transmission of HIV Disease